Winship Cancer Institute Cancer Center Support Grant

PROJECT SUMMARY/ABSTRACT
The Winship Cancer Institute of Emory University (Winship) is the only NCI-designated cancer center in Georgia,
which is now the eighth most populous state and has the largest land area among states east of the Mississippi
River. As the main tertiary cancer care and cancer research institution in the state, Winship has committed its
four research programs as supported by its six shared resources to address the specific challenges associated
with the cancer burden in Georgia. These challenges include: high tobacco usage and incidence of tobacco-
related cancers; high proportion of cancer patients who are African American or black and/or have significant
cancer disparity issues in their care, prognosis, and/or outcome; and low health literacy levels. Winship's mission
is to lessen the burden of cancer for the citizens of Georgia, its primary catchment area. This will be accomplished
by: (1) seeking greater insights into the molecular, genetic, and epigenetic basis of cancer; (2) discovering new
knowledge that drives improvements in cancer detection, prevention, and/or therapy; (3) developing or defining
novel therapeutic targets and/or agents as a pathway to better cancer therapies; and (4) studying and
implementing population-based strategies to lessen the cancer burden in the state. The 164 Winship core
members are actively engaged in one of four Winship research programs, all of which have a strong emphasis
on transdisciplinary research: Cancer Cell Biology, Cancer Genetics and Epigenetics, Cancer Prevention and
Control, and Discovery and Developmental Therapeutics. Winship's members are supported by six shared
resources: Biostatistics and Bioinformatics Shared Resource, Cancer Animal Models Shared Resource, Cancer
Tissue and Pathology Shared Resource, Emory Integrated Genomics Shared Resource, Emory Integrated
Proteomics Shared Resource, and the Integrated Imaging Shared Resource; and two developing shared
resources: Winship Research Informatics and Intervention Development, Dissemination, and Implementation
Developing Shared Resources. Winship members are currently supported by $84.8M in total research funding
(as of 3/31/2016) awarded via Emory University. Winship members Curran and Bruner serve as PIs on two NCI
awards to the NRG Oncology Foundation for a total of $25.6M in support of clinical research infrastructure.
Patient enrollment in Winship's interventional and non-interventional trials continues to increase, especially
among patients from under-represented minority groups, and these activities have contributed to the FDA-
approval of several novel anti-cancer agents during the present funding period. Winship has outstanding
institutional commitment, with more than $200 million in institutional support committed over the next five years,
a level almost twice that committed in 2011. Winship enjoys the same reporting line and organizational position
as Emory's schools of medicine, public health, and nursing. Winship is uniquely positioned to apply its scientific
strengths, outstanding membership, robust infrastructure, strong institutional support, and comprehensive
training programs to fulfill its mission of lessening the burden of cancer on the state of Georgia and beyond.

Public health relevance
PROJECT NARRATIVE As the first and only NCI-designated cancer center in Georgia, the Winship Cancer Institute of Emory University (Winship) serves the state as its primary tertiary cancer care provider and its primary institution for cancer research, training, and education. Winship is an integral part of Emory University, coordinating the cancer specific research capabilities of the Emory University School of Medicine, Rollins School of Public Health, Nell Hodgson Woodruff School of Nursing, Emory College, and Emory Healthcare. Winship maintains direct responsibility to coordinate the clinical care provided to cancer patients and to oversee and coordinate the quality and multi- and trans-disciplinary nature of care with all relevant units to accomplish its mission to lessen the burden of cancer by aligning discovery and education with cancer prevention and cancer care.